DEVELOP ANTIVIRAL DRUGS FOR CMV INFECTIONS IN AIDS

Development of antiviral drugs for the treatment of human cytomegalovirus (HCMV) infections, particularly in AIDS and other immunosuppressed patients.